Improving the efficacy of cell-based cardiac repair

Project Summary. Outcomes of heart repair with unmodified mesenchymal stem cells (MSCs) have been
suboptimal. While developmental studies indicate a role of Wnt11 in cardiogenesis, Wnt11 signaling in
apoptosis, angiogenesis, inflammation, and cardiac biology in adult organisms remains largely unexplored. We
hypothesize that Wnt11-treated MSCs will induce superior infarct repair through greater MSC retention and
survival, and manifold salubrious molecular effects on the myocardium. This hypothesis will be tested in
cultured MSCs in vitro and a mouse model of reperfused myocardial infarction (MI) in vivo. To enhance the
translational relevance of findings, human bone marrow MSCs and CD34+ humanized mice will also be
used for key experiments. Aim 1 will examine whether recombinant Wnt11 (rWnt11) will render MSCs
resistant to apoptosis and washout. Murine bone marrow MSCs will be cultured in medium alone (control) or
with rWnt11, and expression of adhesion molecules, susceptibility to apoptosis, and the underlying molecular
changes will be examined. The impact of rWnt11 on MSC retention will be tested in vivo following
intramyocardial injection of EGFP+ MSCs after MI. Aim 2 will elucidate molecular mechanisms underlying the
reparative benefits induced by rWnt11-treated MSCs. Angiogenic potential will be assessed by morphology,
transcription factors and structural proteins. The role of Wnt/Planar Cell Polarity and Wnt/Ca2+ pathways will be
interrogated using specific inhibitors. The impact of rWnt11 treatment on the expression of inflammation
modulating molecules will be tested. The impact of rWnt11 on MSC secretome and the miRNA cargo in MSC
extracellular vesicles will be analyzed. Aim 3 will establish whether transplantation of rWnt11-treated MSCs
will induce superior infarct repair in vivo, and further identify the mechanistic basis in a definitive fashion. MSCs
cultured in medium alone or with rWnt11 will be injected into the infarct borderzone 2 d after a reperfused MI.
Serial echo and a terminal hemodynamic study will be performed to assess global and regional LV function
and structure. LV anatomy, infarct size, myocyte hypertrophy, and fibrosis will be assessed by morphometry in
myocardial sections. The effects of rWnt11-treated MSCs on myocyte apoptosis, angiogenesis, myocyte
proliferation, calcium handling and gap junction proteins, myocardial inflammation, macrophage populations,
and oxidative stress will be determined quantitatively at both early and late time-points. Focused proteomic
analysis will identify novel myocardial protein modifications. In a comprehensive and thoroughly mechanistic
fashion, these studies will establish whether rWnt11 treatment can improve MSC-induced infarct repair. The
impact will be two-fold: (i) the generation of an effective cellular product for heart repair that can be produced
easily in a GMP facility will have major therapeutic potential for patients with ischemic heart disease; and (ii)
extensive molecular studies will yield novel biological insights about Wnt11 signaling in adult cells, and may
also discover additional therapeutic targets to further enhance Wnt11-based cellular reparative strategies.

Public health relevance
Project Narrative. Ischemic heart disease continues to remain a highly prevalent cause of death and morbidity worldwide. Although recent studies suggest that cellular therapy can repair hearts after heart attacks, the benefits have been suboptimal, and the underlying mechanisms remain unclear. If pretreatment with recombinant Wnt11 can transform MSCs into superior cellular substrates for the repair of failing hearts after a heart attack, this approach may be utilized to generate a much-needed cellular product for therapy in patients. The results of the proposed studies will therefore be highly relevant for public health, and for improving the length and quality of lives of millions of patients with ischemic heart disease and heart attacks.